Exploring CRMP5 as a novel target for Alzheimers disease

ABSTRACT
Alzheimer’s disease (AD) is a devastating disease that bears a huge emotional and socio-economic burden.
Because of the aging population of our societies, the increasing risks of developing Alzheimer and the lack of
proper disease-mitigating strategy, AD is now viewed as a global and urgent crisis. In this proposal, we suggest
a new therapeutic target: Collapsin Response Mediator Protein (CRMP)-5, an inhibitor of tubulin polymerization
and neurite outgrowth. The rationale here is that targeting proteins that restrict neuronal connectivity of the
hippocampus, a prime region of neuronal loss in AD, could prove a valid strategy to mitigate neurotoxicity in AD
and decrease its burden. In the hippocampus CRMP5 interacts with tubulin in the growing axon thus halting its
growth and negatively regulates neurogenesis. In brains from AD patients, CRMP5 expression is increased in
the hippocampus and in the pre-frontal cortex. This supplement builds on the observations that (i) CRMP5
expression was increased in the 3xTg mouse model of AD, (ii) increased CRMP5 expression reduced
socialization in 3xTg-AD mice, (iii) CRMP5 knockdown rescued social performance in 3xTg-AD mice, (iv) CRMP5
increases mitochondrial fragmentation, thereby participating in the known dysfunction of mitochondria in the AD
brain, (v) CRMP5 controls the post-synaptic expression of GluN2B, an ion channel implicated in AD-induced
memory impairment. These results show that CRMP5 upregulation is a pathological feature participating to AD
however the function for CRMP5 in the pathogenesis of AD remains unknown. Within this supplement, we will
test the effect of CRMP5 knockout on memory impairment and social withdrawal as well as neuronal function in
a mouse model of AD. To do so, we will breed a J20 mouse line, which overexpresses human amyloid precursor
protein (APP) with two mutations (Swedish and Indiana mutations) linked to familial AD, with our current CRMP5
KO line. We will compare our J20–crmp5-/-compared to J20–crmp5wt mice by evaluating their cognitive behaviors
using the novel object recognition and Morris water maze tests and their social behavior using the three-chamber
paradigm test. We will assess Aβ burden, as well as synaptic integrity in the hippocampus and pre-frontal cortex.
We will also evaluate neuronal loss by immunoblotting using markers of necroptosis, contributing to cell death
in human and AD mice models. Mitochondrial dysfunction, an underlying mechanism of AD pathophysiology, will
be assessed by cellular bioenergetic profiling and Aβ burden in the mitochondria. Using electrophysiology, we
will test synaptic functionality by measuring long-term potentiation (LTP) in hippocampal and prefrontal cortex
slices. We expect that knock-down of CRMP5 in the J20 mouse will result in reduced AD phenotypes, defined
by (i) increasing memory and social behaviors, (ii) decreasing amyloid plaques burden, (iii) improving
mitochondria function, (iv) decreasing neuronal death, and (v) enhancing synaptic integrity and function. This
Administrative Supplement request in response to NOT-AG-22-025 will help kickstart a larger and more
comprehensive study to evaluate the targeting of CRMP5 to decrease the burden of AD symptoms.

Public health relevance
Narrative Alzheimer’s disease (AD) is the leading cause of age-related dementia and the sixth-leading cause of death in the United States. This supplement will explore the role of a protein upregulated in AD, CRMP5, in the pathogenesis of AD.